Chemistry-Biology Interface Training Program at the University of Florida

The University of Florida Chemistry-Biology Interface (UF-CBI) Training Program is
primarily a partnership between the Department of Medicinal Chemistry and the Department of
Chemistry and takes advantage of the existing recruiting and academic training frameworks
provided by these graduate programs, and the recent expansion in junior and senior research
training faculty across campus. The overarching goal of the program is to develop and expand a
diverse and talented pool of professional researchers with the skills to pursue successful careers
in the biomedical workforce. The UF-CBI Training Plan proposes a series of high impact training
experiences designed to enhance existing departmental predoctoral training activities, and
broadly impact all students in the participating programs. Key elements include: core courses
within a flexible and customizable curriculum; monthly research in progress seminars;
participation in the yearly UF Drug Discovery Symposium, and biennial Florida Heterocyclic and
Synthetic Chemistry Conference, a yearly orientation providing a forum for feedback; training in
rigor and reproducibility, training in scientific communication skills, and a continuing commitment
to inclusion, diversity, and science outreach. Benchmarks for success will be an increasingly
diverse cohort of UF-CBI Trainees and Faculty Trainers, the highest level of retention for all
trainees, a high level of research productivity, and successful transition into biomedical research
careers that fully capitalize on their doctoral training. Critical evaluation of these benchmarks will
be achieved through the implementation of a quantitative assessment plan.

Public health relevance
The goal of this CBI training program is to develop next generation leaders of chemical biologists who will tackle the most significant scientific questions, with particular focus on topics in molecular probe and drug discovery. This program leverages the unique research and educational environment at the University of Florida to provide graduate students from medicinal chemistry, chemistry, biochemistry, biology, biomedical sciences and chemical engineering knowledge, skills and career development opportunities to work together collaboratively in interdisciplinary teams. Students will be trained as experts on both chemistry and biology knowledge domains and can make an impact on health-related research needs.